Critical Resources Provided by UNMC RAP Biorepository Stimulate Cancer Research

Project Summary
The highly innovative Rapid Autopsy Program (RAP) addresses a major limitation in pancreatic and prostate
cancer research: the lack of quality human specimens of cancer representing all stages of disease. This
program, led by Dr. Paul M. Grandgenett, which includes rapid collection of large quantities of all organs and
fluids within 5 hours of death, is a unique program in the world and is designed to maintain cellular and
molecular integrity of the tissue. The RAP is a core component of the University of Nebraska Medical Center
(UNMC) Pancreatic Cancer Research program and the GU Oncology Focus Group, that is tasked with the
collection, archiving and distribution of tissues and fluids from patients that have recently passed with pancreas
or prostate cancer. The Unit Director of the Pancreatic Cancer Research program at the Fred and Pamela
Buffett Cancer Center is Dr. Michael A. Hollingsworth, while the prostate group is led by Dr. Surinder Batra and
Dr. Shawna Boyle. Dr. Grandgenett, a Research Associate Professor under Dr. Hollingsworth's aegis, is the
director of the RAP and the applicant for this Research Specialist Award. The rapid autopsy program operates
within the Pancreatic Cancer Research Program at UNMC and is important to and currently funded in part by:
a pancreatic cancer SPORE p50 grant; ongoing and pending P01 and U01 grants and several R01 grants to
individual investigators. Dr. Grandgenett personally directs the collection of primary tumor, residual unaffected
tissues, distant metastases, all unaffected tissues, as well as fluids such as blood and ascites for all PDAC and
Prostate cancer patients. He has also established an extensive normal tissue acquisition program that is highly
utilized. Dr. Grandgenett determines in advance how specific samples will be prioritized based on the needs of
funded projects both at UNMC and at other institutions. Currently, Dr. Grandgenett provides fresh samples to
multiple laboratories, at UNMC and outside-UNMC, conducting research on blood-based biomarkers (proteins,
RNA, DNA), circulating tumor cells, patient-derived modeling including organoids and xenografts, and other
processes. The remaining samples are snap frozen, maintained in long-term storage and made available
through request and collaboration for local, national and international cancer studies. Key roles of Dr.
Grandgenett is to coordinate the training and participation of the thirty RAP volunteers and to work with
collaborators to determine the samples necessary for their research project, to modify our SOP as needed to
obtain those samples, confirm specimen quality and then to distribute those samples to investigators. It is
essential for the leadership of this resource to be a highly trained Research Specialist with extensive
experience through participation in the autopsies, a comprehensive knowledge of patient sample availability,
as well as the ability to interact on a scientific level with each investigator. Dr. Grandgenett has a major role in
all aspects of the collection, processing, annotation and distribution of these biospecimens and plays a vital
role in expanding collaborative projects with investigators at UNMC and on a national and international level.

Public health relevance
Project Narrative The Rapid Autopsy Program (RAP) biorepository for Pancreas and Prostate Cancer serves as a unique and highly utilized core associated with several NCI funded programs of research in pancreatic and prostate cancer at UNMC and outside institutions. As Director of the program, Dr. Grandgenett plays a major role in expanding the collection, and in the annotation and distribution of these biospecimens. The Director's contribution is essential to the continued success of the program and those dependent on it.